Cellular barcoding of developmental hematopoiesis

PROJECT SUMMARY/ ABSTRACT
Hematopoietic stem cells (HSCs) lie at the top of the blood hierarchy and are capable of giving rise to all blood
cells of an organism. Consequently, their use has enormous therapeutic potential for the treatment of blood
diseases, and generation of HSCs in vitro is a central aim in regenerative biology. Despite this clinical need, we
lack protocols that allow us to efficiently generate HSCs in vitro that are capable of long-term engraftment and
multi-lineage output. A major hindrance is our incomplete understanding of how HSCs are made in vivo. For
instance, although it is established that blood cells develop from endothelial cells in multiple sites throughout the
embryo, we still do not know which embryonic sites produce long-term HSCs, nor how site of origin impacts on
life-long stem cell function or behavior. Furthermore, we are limited in our understanding of the intrinsic and
extrinsic cues driving functional heterogeneity in hemogenic endothelial cells. This project proposes to use
powerful next-generation barcoding technology to enrich our understanding of the embryonic origin of HSCs and
the hemogenic endothelial cell states that give rise to blood to allow us to harness the process in vitro.
Dr. Bowling conducted her graduate work in developmental biology and during her postdoctoral training
has focused on the development of next-generation DNA barcoding tools for performing single cell, inducible cell
lineage tracing in vivo. Equipped with this skillset, Dr. Bowling plans to use innovative cellular barcoding
techniques to, for the first time, catalog the precise endothelial origins of long-lived blood progenitors in the
mammalian embryo (Aim 1). Furthermore, she will perform in-depth characterization of the heterogeneous
endothelial cell states that give rise to distinct blood cells in the embryo (Aim 2). The knowledge generated from
these experiments have the potential to answer major, long-standing questions in the field of developmental
hematopoiesis and transform our basic understanding of the steps leading to blood generation, and therefore
revolutionize protocols for HSC generation in vitro.
Dr. Bowling is supported by a panel of mentors and consultants who are world-class researchers in
hematology, developmental biology, and technology development. Her mentors Drs. Fernando Camargo and
Leonard Zon have made exceptional contributions to the field of hematopoiesis and also have outstanding track-
records for mentorship. Dr. Bowling will gain further scientific training and career development support from her
scientific committee: Drs Jay Shendure, Trista North and Berthold Gottgens. Finally, she will benefit from carrying
out her research program in the scientifically stimulating and resource-rich environment of Boston Children’s
Hospital and Harvard Medical School. The aims in this proposal will allow Dr. Bowling to build on her skills to
gain expert knowledge in the computational analysis of sequencing datasets and the use of induced pluripotent
stem cells, in preparation for her transition to independence. As a result, she will establish a unique niche for
resolving important, clinically-relevant questions in hematopoietic development as an independent researcher.

Public health relevance
PROJECT NARRATIVE Generating hematopoietic stem cells (HSCs) in vitro represents a central aim in regenerative biology due to their significant therapeutic potential for the treatment of blood diseases, including leukemia and lymphomas. In vitro derivation of HSCs for use in the clinic still remains challenging, in part due to incomplete understanding of the steps leading to blood development in vivo. This proposal aims to use next-generation molecular recording technologies to shed light on the biology of developmental hematopoiesis, focusing on the origin, molecular drivers and extrinsic triggers of the process, with the overarching aim of informing and improving strategies for HSC derivation in vitro.